The role of excitatory VTA projections in novelty-dependent behavior

PROJECT SUMMARY
Learning and memory involve multiple brain areas. However, the hippocampus (CA1) and ventral tegmental area
(VTA) are the brain regions primarily involved in novelty detection and context discrimination. Abnormal
connection between these brain regions leads to deficits in novelty behavior. For decades, the function of the
VTA-CA1 circuit in learning, and the dysregulation of midbrain neurotransmitter systems in diseases like
schizophrenia, depression, and addictions have been attributed (primarily) to the dopamine neurons. Because
of this traditional focus on the midbrain dopaminergic systems, the glutamate pathway has been overlooked and
is less understood in normal brain function and neuropsychiatric disorders. In a recent study, we showed that
the VTA glutamate terminals are anatomically dominant in the CA1 while VTA dopamine terminals were limited
to the basal dendrite layer. Functional tracing of the VTA-CA1 pathway shows that selective activation of VTA
glutamate and dopamine neurons has distinguishable effects on CA1 local circuits. Photostimulation of VTA
glutamate – but not the dopamine – neurons increased burst firing of CA1 pyramidal cells. Likewise, stimulation
of the VTA glutamate pathway increased putative pyramidal cells (PYR) excitation of interneurons (INT) in CA1
ensembles. In freely behaving mice, novelty detection tasks that activate the VTA-CA1 circuit increased CA1
PYR/INT connectivity while its inhibition altered novelty-linked behavior. Based on preliminary results, the
proposed research will elucidate the functional significance of the VTA glut→CA1 tract in the hippocampal
encoding of novelty-dependent behavior including context discrimination and habituation. The results of the
proposed research will increase our understanding of VTA excitatory modulation of cognitive processes and
control of adaptive behavior.

Public health relevance
PROJECT NARRATIVE Reciprocal connections between the ventral tegmental area (VTA), a midbrain nucleus, and the hippocampus (CA1) form a loop that governs novelty and discrimination between contexts based on their relevance. Although the VTA contains several neuron types that innervate the hippocampus, the functions of the VTA in the loop have been primarily attributed to its dopamine neurons. The traditional focus on the dopamine pathway significantly limits our understanding of the anatomically dominant VTA glutamate projections in the hippocampus. Thus, the proposed project will use a multi-method approach to dissect the role of the VTA glutamate-CA1 tract in hippocampal encoding and expression of novelty-dependent behaviors.